Administrative Core for the Air pollution disrupts Inflammasome Regulation in HEart And Lung Total Health (AIRHEALTH) Study

ABSTRACT: ADMINISTRATIVE CORE
The overarching goal of the Administrative Core is to provide the operational support necessary to successfully
achieve the goals we have laid out for each project and our program as a whole. The Administrative Core will
serve as a central forum for communication, planning, and common administrative and financial management
among the projects and cores. We will maximize efficiency, cost-effectiveness, and productivity by centralizing
resources used by each of the projects and cores. The Administrative Core will be led by Dr. Kari Nadeau and
will involve the Project and Core leaders and National Heart, Lung, and Blood Institute (NHLBI) Program Staff
on a Steering Committee. Day-to-day operations of the Administrative Core will be overseen by a full-time
Program Manager. The Administrative Core has the following specific aims: Aim 1. provide operational oversight
and integration of projects and cores across the proposed program, Aim 2. provide processes and procedures
for the fiscal administration of the PPG, Aim 3. convene internal and external advisory board meetings and
facilitate meaningful interactions between advisory boards and PPG members, Aim 4. monitor project
productivity and assess use of core resources and Aim 5. broadly disseminate results. Overall, the
Administrative Core will provide fully integrated administrative services for the management, communications,
coordination, and financial administration of our PPG. In doing so, the Administrative Core will support the overall
PPG in transforming our understanding of inflammation-associated cardiopulmonary pathology. The
Administrative Core will provide centralized resources to each project and core, eliminating redundancy and
enabling high-impact research.